Optimization of a personalized skin cancer risk intervention for at-risk young adults

PROJECT SUMMARY
Melanoma and non-melanoma skin cancers are common among young adults. Young adults put themselves at
increased risk for skin cancers due to their tanning habits and inconsistent use of recommended sun protection
methods. Existing interventions for young adults have relied on a one-size-fits-all approach primarily using
appearance-focused appeals examining short-term outcomes, and have not examined potential moderators of
intervention effects. We designed a skin cancer prevention intervention for college students that incorporates
different types of personalized skin cancer risk information (ultraviolet photo showing underlying skin damage,
MC1R testing indicating genetic risk for skin cancer, action planning) to increase receptivity to personalized
risk information and to facilitate decreased tanning and increased use of sun protection. Our study is guided by
the Elaboration Likelihood Model; as such we posit that intervention components will improve outcomes by
increasing central processing of highly personally relevant risk and behavioral planning information. In our
preliminary studies of these intervention components, we observed decreases in tanning behaviors and
increases in sun protection pre- to post-intervention. We propose to apply a Multiphase Optimization Strategy
to identify which of the proposed components or their combinations optimally prevent sunburn, and
secondarily, which elements discourage tanning and increase use of sun protection in college students over
longer term intervals (12+ months). Through a full factorial experiment, we will examine the effects of three
personalized risk components: 1) UV photo; 2) MC1R genetic testing results; 3) action planning. We will
explore socio-demographic and behavioral moderators of the intervention effects in order to inform the
development of future deeply-tailored, optimized adaptive interventions. This project addresses the critical
need for efficacious skin cancer preventive interventions for young adults in the college setting. The project will
also lead to new scientific understanding of moderators of the intervention effects, which will lead to more
deeply tailored interventions that better meet the needs of all young adults.

Public health relevance
PROJECT NARRATIVE To address increasing skin cancer rates in the US, particularly among young people, we propose to use the Multiphase Optimization Strategy (MOST) to evaluate individual and combined effects of action planning, personalized ultraviolet (UV) photographs, and MC1R genetic testing on preventing sunburn, motivating sun protection, and discouraging tanning in young adults. This project addresses the critical need for efficacious skin cancer preventive interventions for young adults in the college setting.